BRAIN CONNECTS: Center for a pipeline of high throughput integrated volumetric electron microscopy for whole mouse brain connectomics

Project Summary:
Center for whole mouse brain connectomics using high-throughput integrated volumetric
electron microscopy (HIVE)
Two fundamental components of the structural basis of brain function are cell type composition and the
wiring diagram between those cells. Over the past decade there has been paradigm-shifting progress in
understanding cell type composition of the brain. Now it’s time to systematically uncover the brain’s wiring
diagram and place it into the context of cell types. Knowledge about the complete connectomes in C. elegans
and Drosophila have revolutionized the understanding of cell types and circuit function in those systems.
Transmission Electron Microscopy (TEM) has consistently led progress in that revolution and has the potential
to scale up to the entire mouse brain with technical improvements in certain areas. During the IARPA MICrONS
project, members of the HIVE team built a complete pipeline to section and image the mm3 and created the data
processing, reconstruction and analysis infrastructure to make cells and connections analyzable. The result was
a dataset with the largest EM level reconstructions of cells in any system, with neurons containing more than
14,000 inputs and 15,000 outputs. We accomplished this by applying a rigorous structured science process that
is a hallmark of the Allen Institute’s team science approach.
In this project we aim to improve our pipeline, developing critical technologies to tackle the challenges of
scaling up to the whole mouse brain and linking to cell types. Our proposal will prepare and section an entire
hemisphere, image it at 120 nm resolution, and image up to 10 mm3 at synaptic resolution within the Cortical
Basal Ganglia Thalamic loop to provide key insights into circuit mechanisms within this circuit. To accomplish
this, we will need to improve all individual aspects of the pipeline, while maintaining consistent integration tests
that ensure that the pieces work together. We will standardize a whole mouse brain staining protocol and
advance the automation of serial sectioning to collection of serial TEM sections across a whole mouse brain.
Developments of serial section tilt TEM tomography will allow to scale EM imaging to a whole mouse brain at
multiple scales, leveraging the re-imaging capacity of serial section TEM. We will develop open source data
processing tools to bring down the cost of segmentation and while improving accuracy and integrating with a
real-time globally accessible proofreading and analysis platform. Finally, we will integrate our data with full
morphology reconstructions linked to gene expression, allowing us to create an integrated atlas of cell types
and connectivity. Our dissemination strategy will further amplify our impact by democratizing access for both
the scientific and educational community.

Public health relevance
Project Narrative The mammalian brain is the most energy efficient, compact, adaptable, intelligent system that we know and understanding it will have a profound impact in our society, technology, economy and mental health. Critical to this understanding is the knowledge about the synaptic structure of neural circuits because it provides strong constraints on the nature of the computations the brain performs, as well as knowledge of gene expression because it provides constraints on how this structure is built and operates. The goal of the proposed research is to create the technologies to scale synapse mapping to a whole mouse brain and integrate this knowledge with gene expression data using as biological model and feasibility test the Cortico-Thalamic-Basal-Ganglia loop.